Bladder Cancer Risk and Genomic Alterations

DESCRIPTION (provided by applicant): This proposal is based on a model of urothelial cancer in which tumors develop along two histologic and molecular pathways: Low grade superficial tumors (pTaGi), which have frequent recurrences but rarely progress to muscle invasion;and high grade tumors which present either with early invasion into the lamina propria (pTiGs), or with more extensive muscle invasion (pT2-T4). We and others have identified a number of candidate genes and chromosomal alterations which are associated with these different pathways, and with clinical outcome. We hypothesize that overall genomic instability and specific genomic alterations are associated with environmental risk factors and with patient outcome. The overall design of this study is to characterize over 800 bladder tumors by array CGH and gene-specific analyses to define associations of molecular alterations with environmental exposures and with clinical outcome. These tumors have already been collected with associated data by our Spanish and NCI collaborators. We will validate associations between genomic alterations and patient outcome on a separate set of tumors collected as part of the International Bladder Tumor Marker Group. Specifically, we propose to: Aim i. Identify molecular alterations associated with environmental exposures in bladder cancers from the Spanish/NCI EPICURO Study. lA) Characterize molecular and genomic alterations in 250 pTa/Gi and 250 pT2-pT4/Gs tumors. Fraction genome altered and loci of specific alteration including DNA amplifications and homozygous deletions will be studied by array-CGH, expression signature by quantitative RT-PCR, and sequencing will identify mutations in pss and FGFRs. iB) Identify associations between environmental exposures and genomic/genetic alterations in the pTa/Gi and pT2-pT4 tumors applying a Case-Case- Control study design. Exposures to be tested will be tobacco smoke and trihalomethanes, which showed the strongest effects in the Case-Control study. Aim 2. Identify genomic and gene-specific alterations associated with patient outcome in both pTa and pT2-T4 tumor groups from the EPICURO study. Array-based CGH and gene-specific expression analyses will be tested to confirm genetic signatures predictive of patient outcome. Aims. A second cohort of 300 pTs muscle invasive tumors will be used to validate the predictive signatures tested in Aim 2. These tumors are being collected as part of International Bladder Tumor Marker Study to evaluate predictive markers in urothelial cancer. Relevance: Bladder cancer is a major cause of morbidity and mortality in the United States and internationally and is among the top 5 in cancer incidence. This study will identify whether environmental exposures lead to genetic alterations in tumors, and whether such alterations predict patient outcome.